THE EPIDEMIOLOGY OF CANDIDA BLOODSTREAM INFECTION

To determine rates of candida bloodstream infection and death. The degree of clustering of strains and the rate of health care workers as transmitters of candida will be examined.